Feasibility Trial of a Mindfulness-basedmHealth Intervention to Mitigate the Effects of Chronic Workplace Stress among Juvenile Justice Officers

Juvenile justice officers (JJOs)—responsible for the over 1 million youth arrested each year in the U.S.—face
exceptionally high chronic workplace stress. This stress is implicated in a constellation of adverse outcomes
underpinned by emotion dysregulation: depression, anxiety, and workplace burnout. Importantly, JJO workforces
are comprised heavily of Black/African American and Latinx employees, and these same groups face disparities
in mental health symptoms and burnout compared with peers from other racial/ethnic backgrounds. Interventions
that address the effects of chronic workplace stress among JJOs thus stand to yield meaningful public health
benefit while helping redress health disparities. Mindfulness-based interventions (MBIs) improve emotion
regulation and reduce depression, anxiety, and burnout. JJOs express strong interest in MBIs, which can be
tailored and delivered to employees during their workdays via mobile health (mHealth) technology. This project
will adapt an MBI smartphone app for delivery to JJOs based on empirically-supported adaptation targets, and
will conduct a feasibility clinical trial. It will build on parallel procedures and technology developed through a prior
NIH award to adapt and test an MBI app for arrested youth, offering a unique, efficient, and cost-effective
opportunity. The study will take place in Chicago Cook County, the 2nd largest juvenile justice system in the U.S.,
where the study team has conducted NIH-funded research for 18 years. To guide adaptation and implementation
of the app, the team will conduct key informant interviews rooted in a theoretically-driven implementation science
framework. Interviews will be held on both the individual (JJO) and organizational (leadership) levels. The team
will work with professional programmers to translate the interview findings into a secure app adapted from
existing source code. For the feasibility clinical trial, JJOs (n=50) will be individually randomized to use the
adapted MBI app or an equally intensive control app daily for 30 days. In-app analytics will capture objective use
of each app feature. An adaptive intervention design will be employed to engage non-users of both apps,
whereby analytics data indicating non-use will trigger delivery of an enhanced engagement strategy (e.g., text
messages encouraging use). Mental health symptoms and burnout among JJOs will be assessed at baseline,
1, and 6 months via self-report. JJOs will also complete 1-week “bursts” of ecological momentary assessment
(EMA) of their objective contexts and affective states at baseline and 1 month in order to capture the mechanistic
target (i.e., emotion dysregulation) in the workplace. At 1 month, both JJOs and leadership will report on
acceptability and feasibility via an in-depth, mixed-methods design. Completion of this study will develop building
blocks for high-impact, large-scale trials that formally evaluate the adapted MBI app. The use of theoretically-
driven implementation science principles coupled with mHealth technology will position the MBI app to be
sustainable and scalable across diverse juvenile justice systems, improving the health trajectories of their
frontline workers.

Public health relevance
Juvenile justice officers experience exceptionally high levels of chronic workplace stress, leading to costly outcomes including depression, anxiety, and burnout. Mindfulness-based interventions (MBIs) improve each of these outcomes, and can be tailored and delivered to employees during their workdays via smartphone app. By adapting an existing MBI app for JJOs and conducting a feasibility clinical trial, this study will develop building blocks for high-impact, large-scale studies that systematically address the need for sustainable and scalable programming to improve health trajectories among the justice system’s frontline workers.